Regulation of Myocardial Phospholipases and Lipases in Diabetic Myocardium

ABSTRACT
Heart disease is the most common cause of death in industrialized nations. The presence of underlying diabetes
is the greatest risk factor for the progression of heart disease. During the current grant interval, we have
discovered previously unknown lipid metabolic pathways and signaling molecules which lead to the generation
of eicosanoid-lysophospholipids. Remarkably, the vast majority of eicosanoids in myocardium were found to be
esterified to the glycerol backbone of lysophospholipids. In addition, induction of Type I diabetes in wild-type
mice or ischemic damage in isolated wild-type mouse hearts resulted in dramatic increases in pro-inflammatory
eicosanoid-lysophospholipids. This new class of phospholipids serve as inflammatory mediators by inducing the
release of TNFa from monocytes or macrophages. Importantly, genetic ablation of iPLA2g (PNPLA8)
substantially decreased the levels of eicosanoid-lysophospholipids in myocardium in the diabetic state, during
myocardial ischemia and synergistically decreased their synthesis in diabetic myocardium rendered ischemic.
Accordingly, we propose that iPLA2g plays a central role in the pathophysiologic development of diabetic heart
disease and promotes the lethal sequelae of diabetic cardiomyopathy. In Specific Aim 1, we will utilize stable
isotope labeling of isolated perfused mouse hearts from genetically engineered cardiac myocyte-specific
conditional iPLA2g knockout mice we have generated. These studies will investigate the roles of iPLA2g in the
metabolic flux of: 1) non-esterified and esterified eicosanoids; 2) eicosanoid-lysophospholipids; and 3) other
salient oxidized phospholipids. Stable isotope pulse-chase experiments followed by penetrating bioinformatic
analyses will determine rates of metabolic flux through these newly discovered pathways. Translationally, we
will explore the impact of Type 2 diabetes on myocardial ischemic damage and the potential salvage of ischemic
myocardium in cardiac myocyte-specific iPLA2g KO mice we engineered. Endpoints of analysis include infarct
size, hemodynamic performance, and post-translational modifications of iPLA2g. In Specific Aim 2, we will utilize
cardiac myocyte-specific iPLA2b KO mice we have generated to explore the role of iPLA2b in promoting
myocardial ischemic damage and arrhythmias in WT vs. iPLA2b KO mice in the context of Type II diabetes. Next,
we will determine the ability of iPLA2b to catalyze acyltransferase or transacylase mediated re-esterification of
eicosanoid-lysophospholipids to generate oxidized phospholipids which have been implicated in damage
associated molecular patterns. In Specific Aim 3, the mechanisms through which a high fat diet induces
eicosanoid-lysolipid synthesis accompanied by inflammation and mitochondrial dysfunction will be studied. The
roles of lysophospholipases in modulating eicosanoid-lysophospholipid levels and activation mechanisms for
iPLA2g will be examined. Collectively, the proposed studies will establish the significance of iPLA2g and iPLA2b
in mediating the newly identified pathways of eicosanoid-lysophospholipid synthesis and metabolism and
determine their impact on diabetic cardiomyopathy and acute ischemic damage in diabetic hearts.

Public health relevance
Heart disease is the most common cause of death in industrialized societies. Diabetes is the largest comorbid factor in ischemic heart disease. The significance of the proposed studies is understanding the mechanisms through which heart disease in diabetic patients is accelerated. In the proposed research, we will explore the roles of new metabolic pathways we have discovered in promoting diabetic cardiomyopathy and tissue damage during heart attacks.